Use of Inter-Hospital Transfer Services in Critical Illness and Acute Respiratory Failure

PROJECT SUMMARY/ABSTRACT
This K08 award will establish Christopher Worsham, MD, MPH as a clinician-investigator health
services researcher examining critical care services and their value using advanced methods of causal
inference. Dr. Worsham is an Instructor in Medicine, pulmonologist, and critical care physician at Harvard
Medical School and Massachusetts General Hospital. Building on his clinical training, prior research
experience, and coursework in quantitative methods, this award will allow him to develop expertise in (1)
advanced methods of causal inference using large administrative datasets, (2) inter-hospital critical care
transport services with an emphasis on acute respiratory failure (ARF), and (3) decision science and cost-
effectiveness analysis. To achieve these goals, Dr. Worsham has assembled a team with expertise in: health
services research and advanced methods of causal inference (Drs. Anupam Jena, Mary Beth Landrum,
Hannah Wunsch, and Bruce Landon); critical care medicine and ARF (Dr. Taylor Thompson); critical care
transport in ARF (Dr. Susan Wilcox); and decision science and cost-effectiveness analysis (Dr. Ankur Pandya).
The inter-hospital transfer of critically ill patients is a common practice in the U.S. critical care system,
generally done to move patients to hospitals with intensive care unit (ICU) resources commensurate with the
severity of their acute illness. However, we do not fully understand current national practice patterns of inter-
hospital ICU transfer across diverse patient populations. We also lack robust estimates of clinical benefits or
value of using particularly costly air ambulance services to rapidly move ICU patients between hospitals,
including those with ARF, the most common reason for ICU admission.
To address these important questions in the critical care system, Dr. Worsham will analyze data from
two large insurance claims databases, Medicare and the MarketScan commercial insurance claims database.
In Aim 1, he will characterize current practices and risk factors associated with inter-hospital ICU transfer in
the overall adult ICU population. In Aim 2, focusing on patients with ARF, he will estimate the effect of air
compared to ground inter-hospital transport using a novel instrumental variables approach that accounts for
unmeasured confounding by taking advantage of the random weather conditions that push patients to travel by
ground rather than air. In Aim 3, he will use methods of decision science to perform a cost-effectiveness
analysis of air compared to ground inter-hospital transport of patients with ARF to inform high-value care. This
work and training will provide him the basis for a future R01 proposal that examines common and costly
practices that impact patients as they move through the U.S. critical care system using advanced methods of
causal inference and cost-effectiveness analysis. This K08 and future R01 will inform bedside decision making
and policy surrounding resource allocation and high-value care in the U.S. critical care system.

Public health relevance
PROJECT NARRATIVE Inter-hospital transfer of patients with critical illnesses like acute respiratory failure (ARF)—by ground or by air—is a common and costly practice in the U.S. critical care system despite a limited evidence base for its efficacy in improving outcomes and unknown cost-effectiveness. The proposed study will use commercial insurance and Medicare claims data to characterize national use patterns for inter-hospital transfer of the broad population of critically ill adult patients; estimate the effect on mortality of air compared to ground transfer of patients with ARF using a novel instrumental variables approach that takes advantage of random weather conditions; and perform a rigorous cost-effectiveness analysis of the use of air compared to ground inter-hospital transfer of patients with ARF. The results of this research will provide physicians, health systems, insurers, and governments with actionable evidence to inform decisions, resource allocation, and policy surrounding inter-hospital transfer within the U.S. critical care system.